Investigating the neural mechanisms of positive and negative social interactions

PROJECT SUMMARY
Mood disorders like major depression are leading contributors to disease burden worldwide. Depression can
cause a wide range of symptoms affecting arousal, motivation, mood, and cognition. Unfortunately, current
treatment strategies are only effective for a subset of patients. While any individual can develop impairments in
these domains of function, there are known risk and protective factors that modify one’s vulnerability. Negative
social experiences like bullying are associated with increased risk, while having positive social support is a known
protective factor. However, the underlying mechanisms by which these risk and protective factors lead to
enduring brain and behavioral changes and how they interact are unknown. To develop more effective
therapeutic approaches for depression and related psychiatric disorders, it is necessary to have a more detailed
understanding of the ways by which conserved neurobiological systems are altered by them.
This proposal will utilize a mouse model of chronic social stress called Vicarious Social Defeat Stress to
comprehensively characterize physiological, behavioral, and neural activity changes associated with negative
social experiences through Aim 1. This model will then be used to investigate the role of a proposed neural circuit
element in the stress ameliorating effects of positive social interactions, commonly referred to as social buffering
in Aim 2. Preliminary data suggests the medial amygdala (MeA) is active during acute stress, which is particularly
interesting given the various known social functions of this nucleus. Subsequent experiments will test the
hypothesis that the MeA is involved in and required for social buffering. In Aim 2, fiber photometry will be used
to monitor MeA neural activity dynamics during post-stress social interactions, which will be linked to
physiological and behavioral outcomes. In Aim 3, chemogenetics will be used to inhibit the MeA during poststress social interactions followed by assessment of physiological and behavioral outcomes to determine its
functional necessity in social buffering. These experiments will improve our understanding of how different social
experiences interact to produce complex behavioral responses, laying the groundwork for future research to
investigate the potential therapeutic applications of this knowledge.

Public health relevance
PROJECT NARRATIVE Mood disorders like major depression are a leading cause of disability and disease burden worldwide disproportionately affecting females, but current therapeutic strategies are often ineffective for many. Designing improved treatments requires a detailed understanding of how the conserved neurobiological systems affected by these disorders become disrupted. This project will investigate how risk modifying factors like social experience and biological sex contribute to enduring brain and behavioral changes, which will inform the development of novel strategies to prevent and cure these burdensome conditions.